Developmental Alcohol Research Training Grant

This is a renewal application for five years of continuing support from an established T32 (AA07453) that was
first funded in 1982. This application seeks continued support for three postdoctoral fellows per year. The
Developmental Alcohol Research Training Program (DART) at the University of Pittsburgh has as its focus
training in the investigation of alcohol use and addiction from a developmental perspective from gestation to
through adulthood. This emphasis addresses the NIAAA strategic plan objective to prioritize research on
alcohol use disorders as developmental in nature. The DART Program is a small, strong, and consistently
productive T32 that has trained 44 postdoctoral fellows, 85% of whom are in academic or research positions.
The trainees have exceptional success obtaining research funding compared to the national average. Their
scholarly output addresses areas of central importance in alcohol research such as onset of alcohol use among
children and ontogeny of risk factors for alcohol use disorder, long-term effects of prenatal alcohol exposure,
health inequities with respect to heavy alcohol consumption and associated precursors, consequences, and
treatment, effectiveness of prevention/interventions for dually-diagnosed patients, psychopharmacological efficacy
in the treatment of alcohol dependence, and the relation between alcohol abuse and the natural history of AIDS.
The DART Program is unique in the NIAAA training portfolio in its focus on development and the large number
of resources available to trainees. The DART faculty are highly experienced, multidisciplinary, and
collaborative and offer direction and mentorship in areas of high priority to NIAAA such as the developmental
stages of alcohol use and abuse, timing and consequences of alcohol use, racial and gender differences, and
the effects of health disparities on the development of alcohol use and misuse. The faculty have expertise in
developmental, epidemiological, clinical, and neurobiological approaches and advanced quantitative methods.
A significant strength of the Program is access to an unusually large number of NIH-funded research projects
that include large, longitudinal cohorts and allow analyses across multiple developmental phases. Supporting
faculty who are not specifically alcohol researchers, but who have expertise in fields such as behavioral and
community health, psychology, pediatrics, and statistics, allow trainees to develop their research with novel
combinations of methods and expertise. Training involves active participation on research projects with
mentors and design of new studies, supplemented by courses in Addictive Behaviors, Developmental
Psychopathology, Epidemiology, and Advanced Quantitative Methods, and by the required Seminar on
Addictions Research (SOAR) and the Career and Research Development Seminar (CARD). The DART
program faculty are committed to training researchers to become independent investigators with the skills and
tools for collaborative, multidisciplinary research in developmental studies of alcohol use and abuse in order to
accomplish excellence and innovation in developmental alcoholism research.

Public health relevance
Excessive alcohol consumption is third among the causes of preventable death in the United States. To reduce this heavy toll on the health of the nation, the next generation of alcohol researchers needs to be trained in the most current and sophisticated scientific methods to understand and to reduce alcohol abuse, dependence, and alcohol-related mortality. This proposal is to train these individuals in an ongoing program that has a history of successfully training researchers in alcohol research.